Stroke and Alzheimers Disease Related Dementias

Project Summary
Stroke - like many brain diseases - is clearly associated with aging and a plethora of age-related co-morbid
conditions, including cognitive decline, Alzheimer’s disease (AD), AD related dementias, multi-infarct dementia,
cardiovascular disease, cerebrovascular disease, hypertension, hypercholesterolemia, immune suppression,
metabolic syndrome and obesity, sleep deprivation, and depression. However, age-related co-morbid conditions,
as a variable in stroke occurrence, severity and long-term recovery is seldom studied experimentally, but is one
of the identified factors in the lack of progress in the discovery of new therapies for acute stroke brain damage.
To optimize the impact of our research on the discovery of new preventatives, acute treatments and rehabilitation
methods for stroke, we need to train the next generation of stroke researchers to assess stroke in the context of
the affected patent population: those who are elderly and have multiple co-morbid conditions. The Stroke and
Alzheimer’s Disease Related Dementias Predoctoral Training Program will formalize and standardize our already
strong training programs in the biomedical sciences and focus on stroke research. A number of innovative
aspects of this training program are semester-long didactic courses in “Stroke” and the “Neurobiology of Aging”,
a clinical immersion in our WVU Stroke Center, a in Stroke Journal Club, an Associate Scholars Program, and
experience in community engagement. The proposed training program will select the best PhD students from
the participating Biomedical Sciences Training programs at the West Virginia University (WVU) Health Science
Center (WVU HSC) and will prepare them with the skills, knowledge and acumen needed for a successful career
in stroke research. The specific training for each of 8 mentee will be tailored based on their annually updated
Individualized Development Plan (IDP), and an “Exploring Career Paths” Program will help prepare them for their
chosen career. Program training is expected to last 2-to-3 years. This pre-doctoral training program will create a
new generation of young scholars who can address the need for innovative stroke research for the citizens of
West Virginia and the nation.

Public health relevance
Project Narrative Public Health Relevance: Stroke - like many brain diseases - is clearly associated with aging and a plethora of age-related conditions, but age-related co-morbidities, as a variable in stroke occurrence, severity and long-term recovery is seldom studied experimentally, but is one of the identified factors in the lack of progress in the discovery of new therapies for acute stroke brain damage. The Stroke and Alzheimer’s Disease Related Dementias Predoctoral Training Program will formalize and standardize our already strong training programs in the biomedical sciences and focus on aging and stroke research by creating a new generation of young scholars who can address the need for innovative stroke research for the citizens of West Virginia and the nation.